Targeted nanotherapy for the prevention of post-traumatic osteoarthritis

ABSTRACT
The latest census indicates that 50+ million adults in the US bear some form of arthritis and by 2030, an
estimated 67 million Americans ages > 18 years are projected to have the diagnosis of arthritis. Osteoarthritis
(OA) represents the most common form of arthritis and is a major cause of morbidity in the aging population
but for which there are limited medical treatments and no disease modifying drugs. Although effective disease-
modifying OA drugs (DMOADs) are critically needed, none has successfully emerged in the clinic. Post-
traumatic OA (PTOA) is a form of OA that develops after a joint injury and in which the nature and time of
trauma is generally known. Approximately 12% of the overall OA burden can be traced to joint trauma. True
prevalence for PTOA may be higher, given the long delay between injury and PTOA (10-15 years). PTOA
affects 5.6 million individuals in the US. The projected lifetime risk of developing PTOA of the knee in
individuals who sustain anterior cruciate ligament (ACL) rupture or meniscal damage is 50-70%. PTOA
accounts for 20% of all joint replacements. Veteran Health Relevance: Among the population of service
members, all causes of PTOA result in some degree of permanent disability in 28% of soldiers compared to
12% of civilians who sustain joint trauma. In addition, the frequency of arthritis among combat veterans from
ongoing US military operations is estimated at 11.8%. The diagnosis of arthritis resulting from combat-related
injury is accelerated and often accompanied by poor outcomes, requiring joint replacement at a younger age in
the veteran population compared to the general population. Thus, any intervention that shifts the curve and
decreases the risk of PTOA development will benefit the patients in the general population as well as military
service members and veterans.
Studies have documented a robust inflammatory response in the immediate aftermath of joint injury (i.e.
during the first week up to 2-3 months) that persists for months to years, albeit at a lower level. This
inflammatory response likely contributes to chondrocyte death, impaired cartilage repair and the subsequent
cartilage degeneration that characterizes PTOA. We posit that modulation of this early inflammation limits
acute cartilage damage while delivery of an anabolic factor that promotes cartilage repair/homeostasis will
further delay or prevent eventual PTOA development. We employed a peptide-based self-assembling
nanocomplex, delivering a wide range of nucleic acids [small interfering (si)RNA and messenger (m)RNA] and
allowing for the simultaneous targeting of multiple pathways using the same cell-penetrating peptide, with no
need for backbone or end-piece alterations. We show that intra-articular (IA) delivery of our peptide-based
nanoparticle to knock down expression of NFKB mitigates early established PTOA in the Destabilization of the
Medial Meniscus (DMM) model of surgery-induced PTOA. We also demonstrate that simultaneous delivery of
NFKB siRNA and mRNA that overexpresses WNT16, a signaling pathway important for the maintenance of
cartilage homeostasis, further mitigates early established PTOA in the DMM model. To explore the unique
potential of our self-assembling peptide-nucleic nanoplatform we propose to determine the long-term outcomes
of combined anti-inflammatory and anabolic nanotherapy in the DMM model. We believe these efforts will likely
produce a disease-modifying nanotherapeutic approach for PTOA. Insight gained from these studies may be
applicable to OA treatment in general.

Public health relevance
Osteoarthritis (OA) is a common form of arthritis, affecting 50+ million adults in the US and for which there is no effective treatment. Post-traumatic OA (PTOA) is a form of OA that develops after a joint injury. It accounts for 12% of all OA and 20% of all joint replacements. Additionally, among combat veterans from ongoing US military operations the frequency of arthritis is estimated at 11.8%. We propose to develop nanotherapeutic approaches that can be delivered into the injured joint to prevent or halt the progression of PTOA. We believe that any intervention that decreases the risk and rate of PTOA reduces the overall burden of OA.